Training Program in Chemosensory Science

ABSTRACT
The overall goal of this T32 Institutional National Research Science Award proposal is to support predoctoral
training in chemical senses research through the Training Program in Chemosensory Science (TPCS) at the
University of Florida. The study of the chemical senses (smell, taste, chemesthesis and internal
chemosensing) has broad impacts on human health, including: the effects of smell or taste impairments (e.g.,
anosmia, phantom tastes, etc.) on eating, nutrition, safety, interpersonal relationships and the incidence of
depression; the engagement of normal smell and taste to promote healthy eating; the contribution of
maladaptive chemosensory behaviors to overconsumption and its related diseases (e.g., diabetes,
hypertension, etc.); and the control of disease vectors and parasites through disruption of host seeking or
reproduction. Unfortunately, chemosensory scientists with the appropriate methodological expertise and
requisite knowledge in this multidisciplinary field continue to be in short supply. This need creates a strong
impetus for building an integrative predoctoral training program in chemosensory science. The chemosensory
research community at the University of Florida – highly diverse in research questions and methodologies, but
organized and integrated through the UF Center for Smell and Taste – is uniquely positioned to lead this
program.The TPCS has four Specific Aims: (1) To conduct a successful program of predoctoral training in
chemosensory science composed of a didactic curriculum, a series of chemical senses research-focused
discussions, a mentored research experience, a patient outreach experience, and professional development; (2)
To link predoctoral trainees with strong research mentors and a multidisciplinary committee of experienced
investigators; (3) To recruit talented and diverse trainees from national and local pools of eligible candidates;
and (4) To evaluate the program in terms of educational objectives tailored to the pre-doctoral program. This
renewal application seeks five years' funding for the TPCS to support four predoctoral students per year (two in
each of two years of training support per trainee) with the aim of producing independent scientists capable of
making significant contributions to the science of smell, taste and chemesthesis. At the conclusion of the period
of support, a diverse group of predoctoral trainees will have been mentored and taught the advanced methods,
fundamental knowledge, and multidisciplinary approaches necessary to further chemosensory research.
Together, this program provides a comprehensive training in chemosensory science that will effectively prepare
our trainees for the wealth of chemosensory science careers available.

Public health relevance
NARRATIVE Training the next generation of chemosensory scientists is essential for developing new treatments for chemosensory dysfunction, promoting better eating habits, enhancing quality of life, and even diminishing disease transmission by vector insects and parasites. The impact of chemosensory dysfunction alone is highly significant, particularly in the age of COVID-19: it is estimated that 10% of people exhibit smell or taste impairments, negatively influencing their diet, danger avoidance, interpersonal relationships and quality of life.